Admixture Mapping of Coronary Heart Disease and Associated Metabolomic Markers in African Americans

Dr. Cruz is a practicing cardiologist with an interest in investigating the genetic underpinnings of circulating
biomarkers and their association with health and disease. Dr. Cruz’s research interests primarily focus on
historically understudied groups and understanding how varied genetic ancestry plays a role in disease
pathogenesis. African Americans suffer disproportionately from many chronic diseases and in particular
cardiovascular disease. African Americans have also not been included in many cardiovascular studies, raising
the possibility that some results may not be applicable to them. Compounding these issues is the fact that
traditional genetic analyses are not designed to account for the relatively complex genetic makeup that African
Americans have, due to their African ancestry and admixture with other populations. This project aims to
identify the circulating metabolites that are associated with coronary heart disease, investigate the portions of
the genome that are of African continental origin, and use this correlation to identify specific genes that are
associated both with African ancestry and coronary heart disease. Through intensive laboratory and didactic
training in metabolomics and genetics, Dr. Cruz will harness the resources of Beth Israel Deaconess Medical
Center, Harvard Medical School, and associated institutions to examine a disease of significant societal
impact. Situated in a multi-disciplinary laboratory, Dr. Cruz will take advantage of novel metabolomic
technologies and novel genetic analytical strategies to better decipher how genetic ancestry influences levels
of circulating metabolites. He will use admixture mapping techniques, which take into account the
heterogeneous genomic make up of African Americans, to better understand how the unique genomic
structure of recently admixed populations may influence baseline circulating levels of metabolites. Using
plasma samples from African American participants of the Jackson Heart Study and Multi-Ethnic Study of
Atherosclerosis, metabolomics will be used to measure levels of circulating metabolites and assess which
metabolites are associated with incident coronary heart disease, with over 15 years of follow up. Clinical traits
associated with coronary heart disease like, diabetes, hypertension, obesity, and hyperlipidemia will also be
analyzed. Using admixture mapping, regions of potential association between the metabolites of interest and
African ancestry in the genome will be identified, allowing for higher power in identifying specific associated
variants in those regions. As precision medicine offers the promise of more personalized care, it is incumbent
on the biomedical research community to take into account the unique genetic makeup of all members of
society. This project aims to offer specific pathophysiologic information for a historically understudied group of
people. Ultimately Dr. Cruz intends on using his research efforts to provide better medical care to understudied
and underserved populations, and in turn improve the health of society as a whole.

Public health relevance
K01 – Project Narrative Investigating the genetic underpinning of circulating meabolitess associated with coronary heart disease in African Americans will help to define the mechanisms by which coronary heart disease develops. It will also help to better predict which patients are at increased risk of developing this disease. Focused on an understudied group, we aim to improve health outcomes by providing more personalized risk assessment for coronary heart disease.